Exposomics and Alzheimer's disease Across the Life Course

Mount Sinai’s Institute for Exposomic Research requests support for an annually held
international series of 5 symposia focused on Exposomics, Aging, and Alzheimer’s Disease
Across the Life Course. The exposome is the study of all the health relevant environmental
factors encountered across life. Exposomics is a complex “big data” science with branches that
include untargeted chemical assays, satellite remote sensing, wearable devices, and social
media mining among other measures. Mount Sinai has been hosting Exposome symposia
annually since 2018 and our team has successfully hosted meetings internationally in Europe
and Latin America already. Our goals are to advance exposomic science globally in order to
accelerate such research in Alzheimer’s Disease and Related Dementias (ADRD). These
symposia will foster new research collaborations and catalyze a critical mass of researchers
working in Aging and Exposomics. Many of the attendees, including junior faculty, are or will
become, future leaders in the exposomics of aging. These conferences will also target important
health issues around ADRD, such as promoting policy and research initiatives designed to
address solutions. Our R13 proposal has multiple highly committed partners already. Our
meetings will be held in 5 locations-Japan, Mexico, France, Rwanda and Nashville TN. Our
program will promote international research in ADRD Exposomic Research and to address the
role of environment in aging processes globally. By doing so, we maximize its impact. Each
symposium is preceded by a ½ day workshop. We will invite prominent speakers from major
research institutions. For example, several NIH Institute directors as well as the NIH ECHO
director have been past presenters. Local experts from the host countries will be prioritized as
presenters, and we will include U.S. leaders in exposomic science and leaders in ADRD
research from across America based solely on merit. Our poster sessions will bring together
junior scientists with established researchers, and we will use R13 funding for travel awards
targeting junior scientists, such as junior faculty and trainees from within the U.S. Each
Symposium is evaluated by attendees, and evaluation data will be used to improve each
subsequent symposium. We will track our ability to attract participants from different disciplines.
We also track attendees and employ a Kirkpatrick Model-based survey to measure knowledge
and use of exposomics in attendee research.

Public health relevance
Project Narrative Mount Sinai’s Institute for Exposomic Research proposes a series of 5 annual symposia on Exposomics, Aging and Alzheimer’s disease and Related Dementias(ADRD). Meetings will be held internationally with co-host institutions (see letters of collaboration) in Japan, Mexico, France, Rwanda and in the U.S. at Meharry Medical College. The symposia are designed to promote diverse research in exposomics in ADRD globally.